Systems Biology and Multi-Omics Core (SBMO)

PROJECT SUMMARY/ABSTRACT
The overall goal of the Systems Biology and Multi-Omics Core (SBMOC, Core C) is to establish local infrastructure
in the Indiana Center for Musculoskeletal Health (ICMH) to support the unique and undiscovered technical solutions
for advancing genomic and metabolomic applications specifically, in the field of musculoskeletal science.
This unique innovation would parallel the adaptation of high-throughput omics approaches well established in oth-er
fields such as cancer biology and neurological diseases. This core will address the unique aspects of working
with skeletal muscle (e.g., multi-nucleation, predominantly sarcomeric protein), bone (e.g., isolation of osteocytes,
osteoblasts, osteoclasts from densely mineralized matrices that are difficult to overcome), and tendon/ligament
(e.g., isolation of tendon cells from a tough, fibrous environment). The SBMOC will also serve as an educational
hub for ICMH investigators to design musculoskeletal genomics and metabolomics studies, emphasizing training
in study design, data integration, interpretation, and insights. The ultimate aim of the core is to use the investigatorgenerated
large datasets along with the publicly available data to yield new mechanistic hypotheses and discoveries
in the musculoskeletal field by leveraging the computational, bioinformatics, genomic, and metabolomics infrastructure
in the Indiana University School of Medicine. SBMOC will be founded as an extension of existing and
highly successful institutional cores and centers, namely the Center for Medical Genomics, and the Center for
Computational Biology and Bioinformatics, along with a newly established state-of-the-art metabolomics facility.
The creation of the SBMOC will allow the three units to coordinate the critical services to all ICMH investigators,
including study design, assay selection, data generation, data processing, data interpretation, data integration and
data dissemination. In addition to providing critical coordination between these three resources and offering subsidized
service rates, the SBMOC will also facilitate new technology and methodology development and implementation
which will be crucial to promoting musculoskeletal research. In summary, SBMOC will facilitate musculoskeletal
research through the following aims: (1) Provide and further develop state-of-the-art genomics services to
meet the needs of ICMH members to advance their musculoskeletal research programs; (2) Perform and customize
state-of-the-art metabolomics services to meet the needs of ICMH investigators; (3) Integrate datasets from
various omics platforms to address research hypotheses and develop novel research directions; and (4) Facilitate
development of ICMH investigator knowledge of, and training in, omics-based approaches to enable expansion of
systems-level experiments. The SBMOC will provide the musculoskeletal research community with cutting-edge
genomic and molecular biology services, bioinformatics/big data computational processing and handling, and
multi-platform omics integration, network, to address high-impact scientific questions and expedite discovery of
treatments and therapies for MSK diseases.